2023 Water Disinfection, Byproducts and Health Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY/ABSTRACT
Disinfection byproducts (DBPs) are an unintended consequence of the application of chemical
disinfectants/oxidants for drinking water disinfection. Since some of these DBPs are toxic, a balance has to be
found to provide microbiologically safe drinking water while DBPs are kept at the minimum. Despite a
significant effort over the last decades this problem has not been solved satisfactorily, partially due to non-
wholistic approaches. The Gordon Research Conference on “Water Disinfection, Disinfection Byproducts and
Health”, which was initiated in 2006 has contributed significantly to a better management of drinking water
disinfection by a strongly interdisciplinary approach. The proposed 2023 GRC is the 7th meeting of this
successful series. It will comprise of 9 sessions, which will cover all important factors of microbial drinking
water quality, disinfection and byproduct formation and human health implications. The program was
developed to embrace a wholistic approach including both cutting edge research and its implications for
provision of drinking water in the 21st century and beyond. The conference will cover 5 general main areas of
importance also including aspects of future impaired quality of water resources: (1) Microbial and chemical
quality of drinking water and health implications, (2) detection of novel DBPs and their toxicity, (3) mechanisms
of DBP formation, (4) exposure to DBPs and epidemiological consequences, (5) development of novel drinking
water strategies and regulatory guidelines. The success of the 2023 GRC will be based on a well-balanced
selection of invited speakers and discussion leaders from different academic and practical fields.
The 2023 Gordon Research Conference entitled “Water Disinfection, Disinfection Byproducts and Health:
Challenges of Disinfection and Oxidation Processes to Provide Safe Drinking Water in a Changing World” will
be held at Mount Holyoke College in South Hadley, MA from July 30 - August 4, 2023. A Gordon Research
Seminar (July 29-30, 2023) will precede the GRC and provide an opportunity for graduate students,
postdoctoral researchers, and early career scientists to present their scientific work and interact in an informal
manner, which will be an important step for the education of the next generation of environmental health
experts. GRS attendees are encouraged to also register and attend the GRC to follow. This GRC/GRS is in
line with the mission of the National Institute of Environmental Health Sciences to “advance research on
environmental triggers of disease” and “foster training and development of young environmental health
scientists and practitioners”.

Public health relevance
PROJECT NARRATIVE The application of chemical oxidants to drinking water has been a successful strategy to fight water borne diseases for many decades. However, the inherent formation of potentially toxic disinfection byproducts (DBPs) from the reactions of chemical disinfectants with water matrix components leads to a need for a more wholistic approach and regulations for future drinking water provision including novel treatment processes and systems level considerations. The GRC “Water Disinfection, Disinfection Byproducts and Health” will cover aspects such as the occurrence and persistence of pathogenic microorganisms, formation and fate of DBPs, DBP exposure and DBP-related epidemiology, toxicity of DBPs, influence of water scarcity on water resources quality and novel treatment options based on cutting edge research to improve drinking water safety.